Project-001

Modified Project Summary/Abstract Section
This application proposes continued funding of the Harvard University Center for AIDS Research (HU CFAR). The HU CFAR is the umbrella and coordinating organization for all HIV research at Harvard, operating out of the Harvard University Provost Office. The HU CFAR serves to integrate HIV research across Harvard affiliated schools, such as Harvard Medical School and the Harvard TH Chan School of Public Health, as well as Harvard-affiliated hospitals and institutes, including Dana-Farber Cancer Institute, Beth Israel Deaconess Medical Center, Boston Children’s Hospital, Massachusetts General Hospital, Brigham & Women’s Hospital, Ragon Institute of Mass General, MIT and Harvard, and Fenway Health. The HU CFAR also has strong collaborations with the Massachusetts Department of Public Health, Boston Public Health Commission and community-based organizations and with global sites, extending its reach to additional key clinical populations and research sites outside Harvard. The HU CFAR leverages strong institutional support to promote multidisciplinary HIV research through its Cores, Scientific Working Groups and Scientific Programs. The HU CFAR includes an Advanced Laboratory Technologies Core, a Biostatistics and Bioinformatics Core, a Bio-Behavioral and Community Science Core, and a Clinical Core. In addition, the HU CFAR Developmental and Mentoring Core supports innovative pilot projects and provides mentorship to develop the next generation of HIV researchers. These Cores are supported by the HU CFAR Administrative Core, which provides administrative support and fiscal oversight and oversees strategic planning. Based on an inclusive strategic planning process, the HU CFAR has also formed steering committees to promote basic and translational science and research on ending the HIV epidemic. Briefly, we propose to: 1. Support innovative, multidisciplinary research initiatives addressing key HIV-related research priorities aimed at mitigating the effects of infection and bringing an end to the epidemic. 2. Engage, support and mentor the next generation of early career investigators in HIV research. 3. Promote and expand Community Engaged Research. 4. Facilitate and expand synergistic multidisciplinary collaborations among Harvard-affiliated HIV researchers and their trainees through innovative leadership, scientific planning and management.

Public health relevance
Modified Public Health Relevance Section The Harvard University CFAR (HU CFAR) provides the infrastructure to coordinate, support and add value to Harvard investigators cutting-edge multidisciplinary HIV research programs and to forge new collaborations and synergies. The HU CFAR pursues innovative initiatives to address critical HIV-related research priorities and train the next generation of HIV researchers. By leveraging the exceptional strengths of Harvard and its institutional support, the HU CFAR promises to continue to provide major leadership in the global effort to prevent and treat HIV.